Validation of Novel Plasma Biomarkers for Mixed Etiology Dementia

PROJECT SUMMARY
In this K23 career development award, Dr. Lawren VandeVrede, a behavioral neurologist and Assistant
Professor at the University of California, San Francisco (UCSF), will obtain training in the use, validation, and
translation of multimodal biomarkers for Alzheimer's Disease (AD) and related dementias (ADRD). This project
supports his long-term career goal to become a leader in ADRD biomarker translation and novel clinical trial
design, and to establish a lab that paves the way for a new generation of clinical trials that will evaluate and
refine treatment approaches for patients with dementia. Through this K23 and the enriched multidisciplinary
training environment at UCSF, Dr. VandeVrede aims to accomplish the following specific training goals: 1) gain
expertise in the use of clinical, neuropathological, biofluid, and neuroimaging biomarker modalities, 2) develop
specialized proficiency in validation of novel plasma AD biomarkers benchmarked to gold-standard
neuropathology and current-generation positron emission tomography (PET) neuroimaging, and (3) develop a
pathway for translation of biomarkers into clinical settings for use as large-scale screening and diagnostic tools
for ADRD. To achieve these goals, Dr. VandeVrede has assembled an exemplary mentorship team, including
his primary mentor, Dr. Adam Boxer, a leader in ADRD fluid biomarker discovery and clinical trial design, and
co-mentors, Drs. Lea Grinberg and Gil Rabinovici, experts in ADRD neuropathology and PET imaging
respectively. In addition, he has two collaborators with expertise in relevant plasma biomarker assays, Drs.
Michelle Mielke and Jeff Dage, and a biostatistician, Dr. John Kornak, with significant expertise in ADRD
biomarker validation and clinical trial design.
The overarching goal of the project is to better characterize the diagnostic performance of several novel AD
plasma biomarkers in an important and clinically relevant patient population: mixed etiology dementia. The
central rationale is that blood tests are critically needed for large-scale diagnostic screening for AD, and
whereas several proposed plasma biomarkers in the research world show promise as future clinical tools, key
validation data and comparisons between biomarkers are missing in real-world dementia patients with mixed
etiology. Therefore, in this project, novel plasma biomarkers of ADRD will be validated (1) in Aim I against
gold-standard neuropathology in autopsy cohorts that include comorbid and alternative neuropathologies; (2) in
Aim II against current-generation PET biomarkers in several prospective observational studies that include
early, mixed, and atypical clinical phenotypes; and (3) in Aim III in a large community-based study specifically
designed to recruit under-represented minorities. This project provides critical data that would support
translation of these specific blood tests into clinical use, and establishes a platform for future discovery and
validation projects for ADRD biomarkers.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease and related dementias (ADRD) are a major public health problem, and our current diagnostic approach for biomarker confirmation of the disease does not meet the clinical need due to challenges with cost, invasiveness, and availability. This project will investigate the utility of several new blood tests for Alzheimer's disease as diagnostic screening tools in a population that represents the full spectrum of neurodegenerative diseases seen in the clinic.